Fighting Obesity by Reinventing Public Transportation: A Natural Experiment

PROJECT SUMMARY
Use of public transit has been associated with increased physical activity, and considered a promising approach to
reducing the risk of obesity and other age-related chronic conditions such as cancer, diabetes, and heart disease. However,
little is known about the physical activity impacts of the increasingly popular Bus Rapid Transit (BRT) which combines
the capacity, speed, and reliability of rail transit with the flexibility and cost advantage of a conventional bus system.
Further, research is lacking about impacts of transit-oriented multilevel interventions (TOMI) that simultaneously
consider multiple synergetic strategies to promote physical activity.
This timely natural-experimental study uses a pre-post (opening of new BRT corridors in El Paso, Texas, fall 2018), case-
comparison design to examine the causal impact of BRT and other supporting TOMI strategies on residents’ physical
activity. The study involves 750 exposed (living within 0.5 miles from a new BRT station) and 500 non-exposed (living
beyond 1 mile from any BRT stations) adult participants who live in the city and do not meet weekly physical activity
recommendations (150+ minutes of moderate-to-vigorous PA) at baseline. The specific aims of this proposed study are to
(1) determine physical activity impacts of BRT; (2) examine physical activity impacts of additional TOMI strategies,
including education (lifting the knowledge barrier by offering a smartphone app and training to assist transit trip
scheduling and to enhance knowledge about using BRT and BRT-reachable physical activity resources) and cost (lifting
the financial barrier to transit use by executing an introductory free-fare strategy); and (3) explore benefits and costs of
BRT implementation, and barriers and facilitators of BRT use. There will be three waves of data collection in spring 2018,
spring 2019, and spring 2021, respectively.
The multidisciplinary team (experts from urban planning, transportation, public health, statistics and disparities research)
proposes many innovative policy, theoretical and methodological advances to understand the obesity reduction roles of
service-oriented environmental interventions. These include a) conceptualization of multi-level factors influencing and
strategies for modifying transit use, b) inclusion of multiple case-comparisons, c) application of relevant methodological
approaches more commonly used in other research queries, and d) a citizen science approach for more contextual
understanding of the PA-transit relationship. Its strong connection with the local communities and stakeholders and
substantial record of research collaboration ensure an effective execution of the proposed research. At the end of the
proposed study, the researchers expect to identify the physical activity impact of BRT and other TOMI strategies, examine
the benefits and costs of BRT implementation, and reveal barriers and facilitators of BRT use.

Public health relevance
PROJECT NARRATIVE Obesity, which poses a major risk factor for the onset or exacerbation of many chronic conditions in the U.S (e.g. cancer, diabetes, and heart disease), calls for innovative intervention approaches to promote physical activity as a major intervention strategy. Although a promising new form of transit that combines the capacity, speed, and reliability of a rail transit with the flexibility and cost advantage of a conventional bus system, Bus Rapid Transit (BRT) has never been rigorously studied for its health-promoting aspects. The proposed project aims to: (1) determine physical activity impacts of BRT; (2) examine physical activity impacts of additional transit-oriented multilevel intervention strategies, including education (lifting the knowledge barrier by offering a smartphone app and training to assist transit trip scheduling and to enhance knowledge about using BRT and BRT-reachable physical activity resources) and cost (lifting the financial barrier to transit use by executing an introductory free-fare strategy); and (3) explore benefits and costs of BRT implementation, and barriers and facilitators of BRT use.